CSHL Cell & Developmental Biology of Xenopus Course (2025-2029)

ABSTRACT
In vivo animal models are an important tool for the understanding of human development and disease.
Studies using the frog Xenopus have made significant contributions to our understanding of fundamental
processes such as cell cycle regulation, transcription, translation and many other topics. Xenopus is
remarkable for studying development and disease, including birth defects, cancer, and stem cell biology.
Because Xenopus are easy to raise, producing many thousands of eggs per day, these frogs have emerged
as a premiere model for understanding of human biology from the fundamental building blocks to the whole
organism.
The Cold Spring Harbor Laboratory course on " Cell & Developmental Biology of Xenopus: Gene
Discovery & Disease" provides extensive laboratory exposure to the biology and manipulation of embryos
from the frogs Xenopus laevis and Xenopus tropicalis. The course prepares students for independent research
in the cell, genetic, and molecular analysis of vertebrate development. It introduces the unique attributes of
Xenopus which allow the functional analysis of developmentally important genes, whilst at the same time
introducing the major technologies of modern molecular and cellular developmental biology, in a system that
allows direct manipulation of embryos and visualization of developmental processes. At the end of the course,
students are ready to embark on cutting edge research using this powerful model of human development.
The Xenopus course is designed to train students how to take advantage of these unique qualities. It
is often difficult for investigators to initiate studies of Xenopus development on their own because the
techniques for raising embryos or manipulating them are unfamiliar or because their background knowledge
of developmental biology is inadequate. This course is designed to provide students with a concentrated and
repeated exposure to the most important research techniques, and the researchers doing them, so that they
initiate their own independent research projects after returning to their home institutions. The course provides
an intensive exposure, over a two-week period, to the biology and manipulation of Xenopus embryos. The
course also provides a resource network that the students can easily access after they have returned to their
home laboratories. Through these routes, the course trains investigators at the advanced graduate,
postdoctoral and faculty levels to use Xenopus in their research
During the course, the students analyze any phenotypes generated from CRISPR/Cas9 based gene
depletion while learning the diverse array of techniques available in Xenopus. In previous courses, we have
guided students in the ablation of a wide variety of genes and helped them design suitable assays for their
biological interests. Most recently, students have targeted autism genes, thyroid genes and immune
modulators, several of which have already led to publications. Approaches covered will include microinjection
and molecular manipulations such as CRISPR/Cas9 knockouts, antisense morpholino-based depletions,
transgenics, and mRNA overexpression. In addition, students can combine these techniques with explant and
transplant methods to simplify or test tissue level interactions. Additional methods include mRNA in situ
hybridization, hybridization chain reaction (HCR), and protein immunohistochemistry as well as basic
bioinformatic techniques for gene comparison and functional analysis. Genomic and systems biology
approaches will be introduced, including single-cell technology. Biochemical approaches such as proteomics
and mass spectrometry and biomechanical concepts will also be discussed. Finally, to visualize subcellular
and intercellular activities, we will introduce a variety of sample preparation and imaging methods including
time-lapse, fluorescent imaging, optical coherence tomography and confocal microscopy.
It is anticipated that the basic organization of the course and some of the basic course material will
remain unchanged during the proposed period of support. However, new and fast-developing topics will be
discussed and integrated into the course as the field progresses.

Public health relevance
LAY NARRATIVE Research into human development depends on the use of animal model systems which share many of the same developmental pathways as Homo sapiens. One important model system is Xenopus, the African clawed frog, which has been extensively used for developmental biology, cell biology, genetics, toxicology, and small molecule screens. The Cold Spring Harbor Laboratory Course on Cell & Developmental Biology of Xenopus: Gene Discovery & Disease is an intensive two week laboratory and lecture course that builds on the prior art developed in this important model organism and provides up-to-the minute training in cutting- edge conceptual approaches and technologies. The course enables the participants to immediately apply advanced techniques using Xenopus in their own research, to network with their research peers, and to learn the challenges and pitfalls through hands-on access to the latest available equipment and reagents.